ND INBRE Health & the Environment

The ND INBRE and the University of North Dakota School of Medicine and Health Sciences is proposing the purchase of a SPECTRAL LagoX instrument to provide advanced rodent imaging technology. The UND SMHS is providing $125,000 towards the purchase price, space for housing within the animal behavioral core facility, and technical support to ensure wide utilization by stakeholders. The LagoX will support the research of multiple CoBRE awards, the DaCCoTA CTR, and multiple investigator-initiated research projects. The ND INBRE research cores are designed to provide state-of-the-art technology that cannot be sent to commercial vendors and must be performed “in house”. These current cores include: microscopy (confocal, fluorescence, laser capture microdisection, and stereology); flow cytometry (including cell sorting); and, animal behavior (including optogenetic capacity). This strategy has been developed due to the low population and large land mass of ND which limits the ability to sustain highly expensive technology that duplicates what is available from commercial resources. The LagoX, while supporting research within ND and surrounding areas, will also provide training opportunities for undergraduate education prior to their entry into postgraduate Ph.D. programs. The ability to engage undergraduates at rural primarily undergraduate institutions and tribal colleges in the use of cutting-edge technology not available at their home institution is a mission of the ND INBRE infrastructure program.

Public health relevance
The ND INBRE is charged with providing the infrastructure to advance research and training for the next generation of researchers and health professionals. The ND INBRE has established core research and training facilities to support this goal.